Identifying Frailty in Primary Care: Implementation of an Electronic Medical Record-based Frailty Index

Project Summary
This Beeson award seeks to equip the candidate, Dr. Kathryn E. Callahan, with the expertise to become an
independent investigator to advance use of aging-related metrics and interventions to promote health, function,
and quality of life in frail and at-risk older adults. Frailty is prevalent among older adults, and associated with
negative outcomes, including hospitalizations, mobility disability, admission to skilled nursing facilities, and
mortality. Despite efforts to define and quantify frailty, time and resource constraints limit the feasibility of frailty
measures in clinical practice. Dr. Callahan's preliminary work supports the feasibility of translating anEMR-
based Frailty Index, or eFI – into the Wake Forest Baptist Health (WFBH) EMR, and demonstrates an initial
association between eFI score and hospitalizations and mortality. The proposed research project represents
critical next steps: (1) to adapt and refine the eFI using ambulatory care data, (2) assess its predictive value for
healthcare outcomes for older adults, and (3) conduct a pilot of implementation in Medicare Shared Savings
Program/Next Generation Accountable Care Organization primary care practices, to collect critical data
regarding feasibility, acceptability, and effectiveness. The scientific goal is to develop and implement an index
to define a population of frail older adults who would benefit from personalized evidence-based interventions.
This work is essential to inform larger-scale implementation trials of interventions to mediate negative and
costly health outcomes for frail older adults. We hypothesize that self-report and functional data from Annual
Wellness Visits (AWVs) in the EMR will further refine the predictive value of the eFI; and that implementation of
the eFI will be feasible and acceptable. This project is supported by engaged mentors (Drs. Williamson and
Boustani) and a highly interactive, inter-disciplinary advisory committee (Drs. Foley, Rejeski, and Pajewski)
whose expertise and complementary skills are a noteworthy asset to this project. We propose the adaptation
and refinement of the eFI within the WFBH EMR, using data from older adults enrolled in the WFBH MSSP/
Next Gen ACO (Aim 1): we will integrate AWV data, and refine the predictive value of eFI scores in this
population. We will then conduct a pilot study implementing the adapted eFI score in six MSSP/Next Gen ACO
primary care practices, and follow health outcomes. The research proposed aligns with an NIA priority to
improve the health, well-being, and independence of adults as they age. It will also provide essential training
for the candidate, who will establish expertise in implementation science, achieve fluency in clinical informatics,
and develop competencies in leading implementation trials. This approach provides the ideal platform to
advance the candidate's career as an independent investigator and provides the foundation to establish frailty
metrics in practice, leveraging the learning health system to implement interventions to improve health and
function.

Public health relevance
Project Narrative Frailty is prevalent among older adults, and predicts poor health outcomes such as hospitalizations, loss of independence, and death; yet measures of frailty are not included in routine primary care practice. Building on our pilot work to generate an electronic frailty index (eFI) in the electronic medical record for older adults, we will adapt and refine an eFI, using already existing data from patients served by primary care practices in our partner Next Generation Accountable Care Organization. We will then test whether primary care providers (a) find value in the eFI when caring for frail and at-risk older adults, (b) change their medical advice and support based on the eFI score, and (c) whether this change improves health outcomes for older adults as a consequence.